The synergy between radiotherapy and angiogenesis inhibi

The goal of this project is to study the interaction of radiotherapy and angiogenesis inhibitors. The majority of inhibitors have been previously shown to be synergistic with radiotherapy. We will examine these effects in vivo and in vitro at the molecular level.